Illuminating the Molecular Logic of Mammalian Synaptic Circuit Assembly

PROJECT SUMMARY/ABSTRACT
Synapses are the fundamental signaling components of the nervous system and mediate trans-neuronal
information transfer. Brain functions require the precise, stereotyped establishment of diverse synaptic
connections into circuits during development, followed by the refinement and maintenance of these circuits
throughout life. Information processing by synaptic circuits underlies the brain's ability to generate behavioral
responses, and circuit alterations are hallmarks of neurological disorders. Despite the importance of synaptic
circuit formation for understanding brain functions and neurological diseases, the fundamental cellular and
molecular framework mediating these processes in the mammalian brain remain unknown. Emerging evidence
suggests that trans-synaptic signaling by networks of cell adhesion molecules directs critical aspects of synaptic
circuit assembly and function. Our previous studies found that the adhesion G-protein-coupled receptor (aGPCR)
Latrophilins (Lphn) mediate the synaptic wiring specificity of the hippocampal CA1 region. aGPCRs exhibit the
unusual dual function of trans-cellular adhesion and control of intracellular GPCR signal transduction cascades.
Studies of aGPCRs provide an opportunity into understanding the mechanisms of circuit assembly and function.
aGPCRs are the second-largest GPCR class containing 33 members in humans that are poorly understood. For
example, while a significant fraction of FDA-approved drugs target well-studied GPCRs, no effective therapeutics
exist presently for aGPCRs although they have been linked to a range of diseases, including cancer, ADHD, and
autism. Many aGPCRs are highly expressed in the brain, but their biological functions and signal transduction
mechanisms remain unclear. More generally, lack of mechanistic insights into brain circuit assembly is precluding
a deeper understanding of behavioral neuroscience and the basis of neurological disorders. Our studies will
interrogate the biological principles of mammalian central nervous system circuit assembly using a
multidisciplinary combination of approaches. First, we will determine the biological functions and signaling
mechanisms of the aGPCRs. These studies will provide insights into an understudied class of GPCR and reveal
novel principles of mammalian central nervous system development. We will subsequently employ genome
engineering combined with live imaging approaches to monitor the dynamics of synaptic connections forming in
mammalian circuits down to the nanoscale level. Our studies will use these approaches to visualize neural circuit
assembly in both aGPCR mouse models and human neurons derived from patients with neurological disorders.
Furthermore, using a combination of molecular and genetic approaches, we will determine the molecular codes
operating in distinct synaptic subtypes during in vivo synaptogenesis. Collectively, these studies will overcome
several current obstacles in the field and illuminate fundamental principles of how the mammalian brain
assembles via synaptic connectivity.

Public health relevance
PROJECT NARRATIVE The mammalian brain is composed of trillions of diverse types of synaptic connections that form precise and stereotyped synaptic circuits essential for brain functions. Despite the importance of synaptic circuit formation, refinement, and maintenance for virtually all behaviors and neurological disorders, the mechanisms underlying these processes remain unknown. Our studies are directed at illuminating how the mammalian central nervous system is wired together into circuits that enable our perception and experience of the world.